Molecular mechanisms of T cell anergy

? DESCRIPTION (provided by applicant): Activation imposes on T cells a high energetic demand that is necessary to sustain effector functions and cell proliferation. If those requirements are not met cells fail to activate and can enter instead a state of unresponsiveness. We have recently shown that activation of macroautophagy, a catabolic process that directs the degradation of different cytosolic components in the lysosomes, in CD4+ T cells is required for the generation of the levels of ATP that guarantee proper activation. Our most recent data supports that if macroautophagy activity is blocked following TCR+CD28 engagement, CD4+ T cells not only fail to proliferate and secrete cytokines but they also become unresponsive, unable to mount productive responses to subsequent stimulations. This places macroautophagy as a key regulator of the establishment of T cell tolerance through the regulation of the cell's energy metabolism. In this proposal we intend to elucidate the molecular mechanisms that regulate the induction macroautophagy in activated T cells and determine how this form of autophagy modulates T cell responses and controls T cell fate. The proposed studies should not only identify a new process involved in the establishment of T cell tolerance but would also identify new molecular targets that can be used to regulate immune tolerance through the modulation of macroautophagy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Different inputs are integrated by T cells to determine their decision to activate or become tolerant. Dysregulation of this decision can frequently lead to autoimmunity. Differences in the levels of activation of the bioenergetic metabolism in T cells have recently been shown to be key determinants during T cell activation and differentiation. We have found that that macroautophagy, a catabolic cellular process that controls the degradation of different cell components in the lysosomes, regulates metabolism in activated T cells. Furthermore, when macroautophagy is blocked T cells not only fail to activate but instead they become tolerant, with greatly diminished capacity to respond to re-stimulation. We intend to characterize this novel regulatory process identifying the mechanism that control it and defining how it modulates the decision between T cell activation and tolerance. These studies will not only set the basis to discover a new regulatory mechanism that controls T cell function, but they should also be able to open venues for the development of new therapeutic interventions aimed at regulating autophagy to modulate immune tolerance and treat autoimmune disease.